Admin-Core

PROJECT SUMMARY - CORE A
The central offices and administrative staff of the Vanderbilt Vaccine Center (VVC) will house the BP4
Administrative Core, which will play a critical role in providing overall leadership and central administrative
support of this Bunyavirus and Picornavirus Pandemic Pathogen Preparedness (BP4) Center. The
Administrative Core aims to support the coordination of efforts across the component research projects and
service core and to support activities to advance integration with the BP4 consortium and the scientific
community. One of the most vital functions of the Administrative Core will be communication between each of
the organizational units within the BP4 Center and with NIAID. The BP4 Administrative Core will coordinate
practical aspects of the program, which include communicating data and information, monitoring, and
managing regulatory compliance. In addition, the BP4 Administrative Core will be responsible for budgetary
management of the program, preparing progress reports, and travel arrangements, which include the BP4
meetings.